Computational, Neural, and Behavioral Studies of Competition-Dependent Learning

PROJECT SUMMARY Our overarching goal is to understanding how stored memories change as a function of experience. The pro- posed work builds on prior research showing a U-shaped relationship between memory activation and learn- ing, whereby strong activation leads to synaptic strengthening, moderate activation leads to synaptic weaken- ing, and no activation leads to no change in synaptic strength. The present grant focuses on the implications of this U-shaped relationship for representational change: Learning is not just about making memories stronger or weaker—it can also decrease neural overlap between memories (differentiation) or increase neural overlap (integration). These neural changes can have profound effects on memory retrieval: Decreased overlap can reduce interference, at the cost of preventing generalization. Our specific goal is to construct and test a com- putational model of representational change and how it is shaped by competitive neural dynamics. When im- plemented in neural networks that are capable of self-organizing internal representations, our theory makes clear, novel predictions about when differentiation and integration will occur: Differentiation of memories A and B will occur when (i) B is moderately activated while processing A, causing weakening of connections between B and A, and (ii) B is reactivated later, allowing it to acquire new features that do not overlap with A; by con- trast, integration will occur if B is strongly activated during A, causing strengthening of connections between B and A. Aim 1 will use neural network simulations to address vexing puzzles in the literature and to generate novel empirical predictions. Aim 2 will test these predictions using behavioral and fMRI experiments focused on learning of new associations in the hippocampus, with a particular emphasis on testing the model's predic- tions about how competitive dynamics relate to representational change. Aim 3 will test the model's predictions regarding cortical plasticity, using a novel sketching task that induces competition between representations of familiar objects. Representational change will be assessed behaviorally in terms of how sketches and object recognition change over learning and neurally using fMRI of visual cortex; a deep neural network model of the ventral stream will be used to measure changes in the features of sketches. In summary: The proposed studies use multiple innovative approaches (fMRI pattern analysis, neural network modeling, free-form object sketching, and computer vision) to address the fundamental question of when experience causes neural repre- sentations to differentiate or integrate, thereby advancing our basic understanding of neuroplasticity. Improving our understanding of neural differentiation could have transformative implications for treating cognitive deficits in a wide range of clinical conditions, including stroke, dyslexia, and dementia. In all of these conditions, cogni- tive deficits can arise from insufficient separation of representations. This research may lead to better ways of re-differentiating these representations and—through this—ameliorating the associated cognitive deficits.

Public health relevance
NARRATIVE This work has the potential to greatly advance our understanding of when learning decreases overlap between memories in the brain (differentiation) or increases overlap (integration). Improving our understanding of neural differentiation could have transformative implications for treating cognitive deficits in a wide range of clinical conditions, including stroke, dementia, and dyslexia: In all of these conditions, cognitive deficits can arise when there is insufficient neural separation of memories or concepts (e.g., temporal lobe stroke can “collapse” stored visual knowledge, preventing retrieval of names of common objects). The learning models and interventions developed here may eventually lead to new and better ways of re-differentiating these collapsed representa- tions and ameliorating the associated cognitive deficits.